Staphylococcus aureus and eicosanoid dysregulation as drivers of inflammation in aspirin-exacerbated respiratory disease

PROJECT SUMMARY
Aspirin-exacerbated respiratory disease (AERD) is a clinical syndrome characterized by asthma, nasal polypo-
sis, and acute respiratory reactions to known cyclooxygenase-1 inhibitors, including the commonly used non-
steroidal anti-inflammatory drugs (NSAID), such as aspirin. Patients with AERD suffer a disproportional burden
of the nasal polyposis and asthma: most AERD patients need repeated sinus surgeries, they tend to have a
more severe asthma, and are more likely to develop upper and lower airway remodeling. There is no labora-
tory diagnostic test available for AERD, often delaying its diagnosis. Polyp growth is associated with a strong
type 2 pro-inflammatory state characterized by high systemic levels of prostaglandin D2 (PGD2) and leukotriene
E4 (LTE4), eicosanoids derived from arachidonic acid. Cyclooxygenase-1 (COX-1) inhibition in AERD causes a
multifold increase in PGD2 and LTE4, while it should instead decrease PGD2 and only minimally change LTE4
levels. This discrepancy suggests dysregulation of arachidonic acid metabolism, likely due to as yet unidenti-
fied factors in AERD patients.
To uncover the role of nasal polyps in AERD pathophysiology, we have studied Staphylococcus (S.) aureus as
a frequent colonizer in the nasal polyp tissue of AERD patients. S. aureus exotoxins are known to activate leu-
kotriene biosynthesis in neutrophils, and the bacteria have also been shown to invade mast cells in nasal
polyps. In the proposed research, we will extend these observations by exploring the effects of S. aureus on
arachidonic acid metabolism, including changes in AERD and non-AERD polyp tissue in response to COX-1
inhibition. Because S. aureus is a pathogen that often evades immune defenses, it is plausible that S. aureus
can impact arachidonic acid metabolism to avoid the host’s antibacterial immune response.
The proposed research will test whether colonization or infection of nasal polyps by S. aureus contributes to
abnormal metabolism of arachidonic acid in AERD patients.
Aim 1: To determine if S. aureus exotoxins increase pro-inflammatory eicosanoid PGD2 and LTE4, levels in
AERD polyp tissue.
Aim 2: To determine the mast cell transcriptional program upregulated in AERD and identify if it is induced by
S. aureus.
The proposed research will potentially yield a new paradigm of AERD pathogenesis in which S. aureus acts as
a major environmental factor that dysregulates eicosanoid metabolism and contributes to AERD. In addition,
understanding this mechanism may lead to the development of novel diagnostic markers and of therapeutic
strategies to target S. aureus or mast cells to limit the extent of type-2 inflammation and improve health

Public health relevance
PROJECT NARRATIVE The proposed studies are relevant to public health as they may provide new proof-of-concept evidence for the role of Staphylococcus aureus in aspirin-exacerbated respiratory disease (AERD). These studies would char- acterize the role of eicosanoids and mast cells in AERD that may lay the groundwork for discovery of novel diagnostic markers and therapeutic strategies to target S. aureus or mast cells to improve health outcomes in AERD patients.